Construction of chondroitin sulfate microarray

Project title: Construction of chondroitin sulfate microarray
The proposal is aimed to develop a high throughput method to study the interactions between
chondroitin sulfate (CS) and proteins. CS is a member of glycosaminoglycan family displaying a
wide range of biological functions. Glycan Therapeutics is a company specialized in CS and
other glycosaminoglycan related research products. In this phase I SBIR proposal, a CS
microarray technique will be constructed. The strength of the company is capable of
synthesizing structurally defined CS oligosaccharides using the enzymatic method, allowing to
synthesize gram-scale of CS oligosaccharide. A single specific aim is proposed in the current
application, which to build CS-microarray analysis technique covering 30 different
oligosaccharides. Three experiments to support the quality control of the technology are
proposed. First experiment is to couple a chemical linker to the synthesized CS
oligosaccharides to allow affixation of the oligosaccharides on the array chip. Second
experiment is to prepare eight fluorescently labeled CS oligosaccharides to evaluate the
efficiency for the affixation to the chip. Third experiment is to identify a CS-binding protein to
serve as a positive control for the CS-microarray analysis. In the phase II studies, the number of
oligosaccharides array slides will be expanded to 200 to fully represent the structures of CS
isolated from natural sources. The success will lead to a convenient approach for improving
research in glycosciences.

Public health relevance
Project Narrative Chondroitin sulfate is a sulfated polysaccharide displaying a wide range of biological functions. In this project, Glycan Therapeutics plans to develop an innovative chondroitin sulfate microarray technology. The success of the project will provide a new tool to study the interactions between chondroitin sulfate and proteins to advance glycoscience research.